Coronary Vascular Resilience by Modulation of Mitochondrial ROS in Endothelium

The main objective of this study is to elucidate molecular mechanisms by which coronary endothelial cells
(EC) can survive and proliferate in ischemic (low oxygen, low glucose) conditions and help improve cardiac
This proposal is based on our recent report that
reduction in mitochondrial (mito)-ROS, using EC-specific transgenic overexpression of mito-antioxidant
MnSOD (SOD-OE) or using mito-specific antioxidant nanoparticle JP4-039, improves survival and
proliferation of coronary EC, and help recover cardiac function in a post-myocardial infarct (MI) animal model.
Coronary ECs from SOD-OE demonstrated 50% reduction in mito-ROS (by mito-roGFP), significant increase
in mitochondrial complexes I and IV biogenesis (proteomic data), super-complex formation, and oxidative
phosphorylation (Ox-Phos).
The shift from less-efficient energy production system glycolysis (2 ATP/glucose molecule), to a more
efficient Ox-Phos (32 ATP/glucose) may provide critical energy support to EC needed during ischemia (low
glucose, oxygen). However, two major concerns about these counterintuitive findings of increased OxPhos in
ischemic EC should be addressed: (1) OxPhos requires oxygen but ischemic EC has low oxygen and high
ROS, and (2) in ischemia, glucose is catalyzed to lactate but not pyruvate that is required for OxPhos. Indeed,
studies reported lactate accumulation during ischemia induced endothelial-to-mesenchymal transition (EMT)
and cardiac remodeling. Here, we hypothesize that reduction of excess mito-ROS by MnSOD during ischemia
results in recycling of endothelial mito-superoxide to molecular oxygen (O2- to H2O2 by MnSOD, and O2 by
Gpx4) to be utilized by mito-complexes (e.g. complex IV) for efficient electron transport chain (ETC) in EC
super-complexes. In addition, glycolytic product lactate is catalyzed to pyruvate for the TCA cycle in EC
mitochondria. We propose 3 Aims:
function by rendering coronary vessels resilient in ischemia.
Specific Aim 1: Elucidate the molecular mechanisms by which
mitochondrial MnSOD protect coronary EC by inducing mitochondrial oxidative phosphorylation and coronary
angiogenesis in ischemic myocardium. We hypothesize that reduction in EC-mito-ROS by MnSOD resulting
in increased OxPhos depends on Gpx4-mediated conversion of mitochondrial H2O2 to oxygen as electron
acceptor at ETC. Specific Aim 2: Elucidate the mechanisms by which coronary endothelial TCA cycle of
OxPhos receive pyruvate/Ac-CoA during ischemia that favors lactate accumulation. Specific Aim 3: Determine
whether mitochondria-specific antioxidant nanoparticles JP4-039 and XJB-5-131 induce post-MI recovery of
cardiac function in large animals (swine) in vivo and increase OxPhos and angiogenic sprouting in human
atrial tissue ex vivo.

Public health relevance
Project Narrative The number of blood vessels that are preserved and/or formed after myocardial infarction (heart attack) is a crucial factor that determines survival and morbidity of the patient. This innovative project will examine whether an increase in mitochondrial oxidative phosphorylation, in addition to glucose-dependent glycolysis, in endothelial cells (EC) for energy supplies (ATP) by modulating mitochondrial oxidant levels can improve viability and proliferation of coronary vascular endothelium in ischemic myocardium. The outcomes will help develop treatment regime for coronary artery disease, heart attack, and also stroke in the long-term.